Improving Rural Access to Pediatric Health Care with Accurate Telehealth Diagnosis of Acute Otitis Media via Wide Scale Use of Smartphone Acoustic Reflectometry

PROJECT SUMMARY
Acute otitis media (AOM) is a common condition, affecting 80% of children under the age of three. There are 30
million annual visits in the United States due to suspected AOM. While telehealth improves access to health care
services, AOM visits are challenging because diagnosis traditionally requires in-person exams. This challenge
is particularly acute for rural children, as studies have shown that disadvantaged children with limited access to
health care services are less likely to receive treatment for AOM and are more likely to develop complications,
such as hearing loss, speech delay, or eardrum perforation. Current telehealth services lack technology to
successfully conduct a middle ear exam. Wavely Diagnostics (“WavelyDx”) has developed a smartphone-based
tool for lay users that accurately detects middle ear fluid (the hallmark of AOM) during a telehealth visit. The
technology uses acoustic reflectometry—an evidence-based technique that reflects sound waves off the
eardrum—paired with advanced signal processing and machine learning algorithms to determine middle ear
fluid. In WavelyDx’s Phase II SBIR project, the company developed the technology so it could be used widely.
In this Phase IIb SBIR proposal the company will remove remaining barriers to deploying the technology at
greater scale. The specific aims are: 1) develop a make-at-home waveguide to remove physical barriers to
widespread on-demand use, 2) clinically demonstrate accuracy of middle ear fluid detection in real-world use, 3)
demonstrate economic Return On Investment (ROI) for care delivery organizations and/or health plans using
WavelyDx to increase the frequency and quality of telehealth use for children. The proposal aims to deliver a
Middle Ear Fluid Scanner for virtual AOM management, enabling widescale adoption by telehealth providers,
particularly in rural communities. With the ubiquity of smartphones, growing telehealth adoption (especially in
rural communities benefiting from broadband expansion), and the need for accurate remote diagnostics, this
system could transform access to health care for 13.4 million children in rural communities.

Public health relevance
PROJECT NARRATIVE Acute otitis media (AOM) is a leading cause of medical visits for children each year, yet these encounters can be challenging for rural children who lack easy access to health care services. This can lead to complications such as hearing loss, speech delay, and eardrum perforation. Wavely Diagnostics is developing a smartphone- based tool to enable timely and accurate diagnosis of ear infections during virtual telehealth consultations, improving health care access for rural and underserved populations by leveraging existing infrastructure, such as smartphones, already available in these communities.